Computational mapping of human B cell migration and differentiation pathways

Human B cells play a fundamental role in the adaptive immune response to infection, development of protective
immunity from vaccination, and pathology of many autoimmune diseases. Central to all of these processes are
migration of B cells among different tissues and differentiation of B cells into functional subtypes. Currently,
understanding B cell migration and differentiation is limited because these processes are dynamic and difficult
to directly observe, particularly in humans. Our previous work has demonstrated that it is possible to detect
migration and differentiation events along evolutionary trees inferred from B cell receptor (BCR) sequences,
which are subject to rapid somatic hypermutation and antigen-driven selection during adaptive immune
responses. This is analogous to viral phylogeography, the use of evolutionary trees to track the spread of viruses
during epidemics. However, there are key differences in the biology of B cells and viruses that require modifying
and extending existing approaches to make them appropriate for B cells.
The goal of this proposal is to enable B cell phylogeography. We will develop novel computational
methods that leverage recent advances in single B cell sequencing technology to infer how B cells migrate
between tissues and differentiate into cellular subtypes based on their activation states during immune
responses. The aims of this proposal focus on solving the roadblocks to the development of phylogeographic
methods for B cells. These methods will be validated by simulations and experimental analysis. We will work
with established experimental collaborators to translate these novel methods into meaningful outcomes in the
research of influenza vaccine response and the treatment of autoimmune diseases, including lupus and
myasthenia gravis. We will implement these methods in widely available free software, which will greatly increase
their potential to inform vaccination strategies against other pathogens like HIV and SARS-CoV-2, as well as
treatment of other B cell-mediated conditions such as multiple sclerosis and asthma.
The K99 phase of this proposal will be guided by Prof. Steven Kleinstein at Yale School of Medicine, a
world leader in computational methods development for BCR sequence analysis, and Prof. Kevin O’Connor, a
leading experimental biologist in the B cell pathology of neurologic autoimmune diseases. The candidate, Dr.
Kenneth Hoehn, has a strong background in genetics and evolutionary biology, and has an established record
of developing evolutionary models to study B cell populations from BCR sequence data. The work detailed in
this proposal will fill gaps in the candidate’s training in B cell biology, single cell analysis, and software
development. The R00 phase will build off of this work to develop a highly generalizable framework for
characterizing the complex migration and differentiation patterns that underlie B cells’ role in vaccination and
autoimmunity. This will support new, medically-relevant discoveries about B cell biology, and serve as a
foundation for the candidate’s future as an independent computational immunologist.

Public health relevance
PROJECT NARRATIVE The proposed research will develop widely-applicable computational methods to make statistical inferences about migration of B cells between tissues and differentiation of B cells into cellular subtypes. These methods will significantly expand the ability of scientists to study these dynamic processes in humans. Working closely with experimental collaborators, we will validate and then apply these methods to several biological systems including vaccination and autoimmunity, in both human and murine model systems.